Molecularly Targeted Probes for Photodynamic Therapy and Imaging of Breast Cancer

Summary: Molecularly Targeted Probes for Photodynamic Therapy and Imaging of Breast Cancer
The goal of this proposal is to test the hypothesis that small, peptide-based molecularly targeted probes
containing a near infrared (NIR) dye and a photosensitizer (PS) dye will be effective for fluorescence imaging
and photodynamic therapy (PDT) of breast cancer (BrCa). This novel treatment method will give patients
access to an unprecedented therapy option, without the burden of side effects from traditional BrCa therapy. In
particular, the application to fluorescence-guided lumpectomy combined with PDT in the same operation is
envisioned as a remedy for the current epidemic of re-operation as it will provide a means of effectively treating
residual BrCa cells in the margins. The strategy relies on a targeting deca-peptide, 18-4, reported to be an
effective targeting agent for the keratin receptor, KRT1, a biomarker that is independent of hormone expression
in BrCa cells. Students in our labs have developed a synthesis of 18-4 by a solid phase peptide synthesis (SPPS)
and have merged that with a modular method we developed for the synthesis of BrCa-targeted molecular
imaging agents (TMIAs). This method will provide analogous molecularly targeted photosensitizer (MTPS)
probes for PDT and dual TMIA-MTPS probes for guiding surgery and PDT. Students at RIT will use confocal
fluorescence microscopy (CFM) to evaluate the affinity of the 18-4-based TMIAs and dual TMIA-MTPS probes
to two triple negative BrCa cell lines, MDA-MB-231 and EMT6, utilizing non-cancerous MCF10A as a control.
The in vitro efficacy of PDT in the same cell lines will next be investigated using a single MTPS probe. To
ensure that single MTPS and dual TMIA-MTPS probes are equally effective, PDT will be investigated in vitro in
the MDA-MB-231 and EMT6 cells lines, using a laser supplied by our collaborator at the U of R. The
mechanism of cell death will be studied using CFM and apoptosis assays. The strategy includes testing the
binding affinity of the single and dual probes to EMT6 tumors in mice by in vivo NIR imaging, then testing
efficacy in PDT experiments after systemic injection of the targeted dual TMIA-MTPS probe. Therapy will be
monitored by tumor dimensions and stereo-fluorescence microscopy to verify efficacy of targeted and
untargeted probes, with and without PDT. The combined in vitro and in vivo experiments will provide an
effective strategy to develop single and dual probes for the PDT of BrCa. A key aspect of this proposal is the
participation of three undergraduates from RIT in each year, one of whom will participate in the in vivo testing
at the U of R, one in synthesis and one in the in vitro analysis at RIT. The collaboration highlights expertise in
synthesis, cell biology, and confocal microscopy at RIT, and in cancer imaging and photodynamic therapy at
the U of R. These combine to provide a vibrant learning environment in cancer research for undergraduates,
with the achievable goal of revolutionizing treatment of BrCa by developing small, peptide-based TMIA,
MTPS, and dual TMIA-MTPS probes to transform BrCa therapy by the use of molecularly targeted
fluorescence-guided PDT and provide a breakthrough in the treatment and cure for BrCa patients.

Public health relevance
Narrative: Molecularly Targeted Probes for Photodynamic Therapy and Imaging of Breast Cancer Photodynamic therapy (PDT) is an emerging cancer treatment that involves treating tumor cells with a photosensitizer (PS) dye that will destroy the cells when the diseased area is illuminated with a laser. If this dye can be attached to a small targeting peptide, it would selectively bind to a biomarker on breast cancer (BrCa) cells, creating a molecularly targeted photosensitizer (MTPS) probe for PDT that will kill BrCa cells selectively, sparing healthy tissue. If we can further add a fluorescent infrared dye we can synthesize a dual targeted molecular imaging agent, (TMIA) -MTPS probe for guiding therapy and test the efficacy of the designed probe in killing BrCa cells using in vitro and in vivo PDT, with the aim of developing a new, minimally invasive treatment for BrCa, without the side effects associated with traditional cancer therapies.